Deep South KUH Premier Research - Interdisciplinary Mentored Education (PRIME) Training Core

TL1 CORE SUMMARY
The overall mission of the Deep South KUH PRIME TL1 Training Core is to provide training in interdisciplinary
and translational research that ensures pre- and post-doctoral trainees will learn the skills and knowledge to
successfully transition to the next steps of their careers in KUH research. To overcome the challenge presented
by a lack of researchers adequately trained in basic, clinical and population sciences, we will develop an
integrated training program that focuses on interdisciplinary and translational research with support from
experienced mentors and enhanced collaboration. The impact of our program will be felt across the Deep South
through established strong partnerships between Augusta University, Tulane University and the University of
Alabama at Birmingham. The TL1 Core is designed to support highly talented trainees from demographically
and scientifically diverse backgrounds. This includes trainees from nephrology, urology, and non-malignant
hematology as well as relevant disciplines in pediatrics, surgery, epidemiology, and engineering among others.
There will be no specific restrictions to joining the KUH PRIME TL1 program across disciplines provided the
research is relevant to KUH science. While we will leverage successful approaches developed for current T32
and related programs and other institutional resources, this new program will broaden the spectrum of research
training to include those not directly funded by the TL1. We will work closely and collaboratively with the U2C
Administrative, Professional Development and Network Cores to develop a seamless process for developing
skills that will be critical for achieving success in the modern workforce. The TL1 Core will work with each trainee
on an individual basis to ensure appropriate mentoring, research opportunities and educational experiences to
meet their personal and professional goals. Further training will include developing skills in managing and leading
research teams critical for future success in KUH research. This effort will encompass the spectrum of trainees
supported by the TL1, institutional trainees supported by extramural awards (R25s, Fs, Ks, CDAs etc.) or other
mechanisms (graduate, medical, and public health schools, residency programs, and basic & clinical fellowship
programs). The TL1 Core has three specific aims: 1: Establish didactic training and instructional programs to
expand the knowledge base and interest in scientific discovery of pre- and post-doctoral trainees in the areas
related to kidney and non-malignant diseases of the upper and lower urologic and hematologic systems, 2:
Develop individual training plans that include instilling a culture of discovery supported by interdisciplinary,
translational activities designed to meet individual interests, needs, and goals, and 3: Collaborate with the
Administrative, Professional Development, and Network Cores to achieve the following mission-oriented
objectives. These include programs to recruit and retain individuals from underrepresented groups, evaluate and
support the training program, personalize research training with writing, presentation and leadership skills, and
foster a larger network of mentors, collaborators and peers to engage the broader scientific community.